Pediatric Malignancies Program

Pediatric Malignancies Program: Summary
The Pediatric Malignancies (PE) Program focuses on malignancies unique to children (neuroblastoma,
retinoblastoma, diffuse midline gliomas, and medulloblastoma), as well as cancers more common in children
than adults: acute lymphoblastic leukemia (ALL), bone sarcomas, and low-grade gliomas (LGG). Pediatric solid
tumors, often embryonal in origin, provide opportunities to understand the links between normal development
and aberrant signaling in childhood malignancies; to discover therapeutic targets; and to integrate these
discoveries into innovative clinical trials. Inherited cancer predispositions, common in pediatric cancers, offer
opportunities to uncover genes and proteins that regulate normal growth and are deregulated in cancer. These
molecular studies also inform interactions between tumors and the tumor microenvironment in cancer
development, understanding the late effects of treatment, and improving the outcome for survivors.
The overall goals of the PE Program are (1) to understand the biology of pediatric malignancies and uncover
links between normal development and cancer to identify therapeutic targets; and (2) to translate laboratory
discoveries into clinical trials, and epidemiological and survivorship studies to improve clinical outcomes for
children with cancer. These goals are addressed by undertaking research in four disease-specific themes:
Theme 1: Acute leukemia
Theme 2: Brain tumors
Theme 3: Neuroblastoma
Theme 4: Sarcoma and other pediatric solid tumors
PE Program: Key Metrics
Membership (12 departments, 2 schools) 30
Full 23
Associate 7
Cancer-relevant Funding (direct costs as of
$14,090,085
05/31/2017)
NCI $4,160,966 30%
Peer-reviewed $5,888,503 42%
Non-peer-reviewed $4,040,617 29%
Cancer-relevant Publications (1/2012-7/2017) 506
Inter-programmatic 201 40%
Intra-Programmatic 139 27%
High-Impact 184 36%
Accruals to Clinical Trials (2016) 188 85
Therapeutic 88 67
Other Interventional 2 5
Non-interventional 98 13